HIV-associated Tuberculosis Training Program (HATTP)

PROJECT SUMMARY
We apply for renewal of the Fogarty HIV-associated Tuberculosis Training Program (HATTP) at the University
of Cape Town (UCT) in partnership with Johns Hopkins University (JHU) and Vanderbilt University Medical
Center (VUMC) building on the successes of the existing training program and productive research
collaborations between these institutions to provide HIV-associated TB (HIV-TB) and HIV-associated COVID-19
training at UCT. The Program addresses the following needs: more clinician scientists/researchers need to be
trained to develop the next generation of scientific leaders in HIV-TB and HIV-COVID-19 at UCT; there is an
urgent need to accelerate transformation of the demographic composition of researchers at UCT to redress
disparities that persist from apartheid; and there are specific training requirements in high-end analytical methods
needed to lift UCT’s capacity to the next level. Six focus areas for training have been chosen: 1) Clinical
Epidemiology and Biostatistics training for clinicians entering research; 2) Advanced Epidemiology and Modelling
of the HIV-TB Epidemic and Interventions; 3) Pharmacokinetics, Pharmacogenetics and Genetic Epidemiology
of HIV and TB drugs; 4) Immunopathogenesis of HIV-TB Co-infection and Disease; 5) HIV-TB Drug
Hypersensitivity: Clinical Epidemiology and Molecular/Immune Pathogenesis Research; and 6) the interaction
between HIV and COVID-19: Clinical Epidemiology and Immunology Research. We will award 15 fellowships (4
postdoctoral, 9 PhD, and 3 Master’s level), spread across the focus areas, with shared mentorship from the
partner institutions. Of these 15 fellowships, 10 will be targeted to emerging black researchers. We will offer the
following additional medium-term training opportunities: 3-10 month training periods at US institutions to learn a
laboratory or analytical method for 4 fellows; attendance at the JHU Graduate Summer Institute of Epidemiology
and Biostatistics for 4 fellows; and web-based epidemiology, biostatistics, and genetic epidemiology courses.
Short-term training will include short courses on topics including grant and protocol writing, epidemiology, and
biostatistics. We will hold monthly fellows seminars and an Annual Scientific Meeting. Seminars will include
fellows’ research updates, Responsible Conduct of Research training, and career coaching topics. A novel
aspect of our Program is the annual “Entry into HIV-TB research” symposium for medical students followed by
electives and ongoing contact, with the objective of having the most talented and motivated students return to
UCT to develop careers in HIV-TB research. The Program is led by Dr. Meintjes (PD/PI) with a Core
Administrative Committee and a Steering Committee representing all partner institutions. Oversight will be
provided by a Training Advisory Committee (TAC) chaired by Dr. Taryn Young (Stellenbosch University) with
three other members (Drs. Aliyu, Beyrer and Mizrahi). An annual structured evaluation process will assess
individual development and overall Program outputs, outcomes, and performance, and will involve a written
report to and feedback from the TAC, which the PI and committees will use to improve the Program.

Public health relevance
NARRATIVE South Africa has among the highest incidence of HIV-associated tuberculosis in the world, with this condition and COVID-19 being leading causes of death in South Africa. This application seeks renewal of the Fogarty HIV- associated Tuberculosis Training Program through which the University of Cape Town is partnering with Vanderbilt University Medical Center and Johns Hopkins University to provide research training opportunities to develop the next generation of researchers working on the epidemiology, treatment issues and immunology of HIV and tuberculosis as well as HIV and COVID-19 interactions. In this Training Program we will place strong emphasis on training clinician scientists/researchers, attracting medical students to HIV-associated tuberculosis and HIV-associated COVID-19 research, and on demographic transformation of the research platform to redress disparities persisting from apartheid.